ShEEP Request for Zeiss Modular Laser Scanning Microscope LSM 980

The Research & Development Program at the James J. Peters VA Medical Center (JJPVAMC) has for many years supported a variety of core equipment items that are available to VA investigators and their collaborators. Among the most utilized core equipment items are a set of microscopes that function as part of a Microscopy Core Facility. Central to the operations of this Microscopy Core is a Zeiss LSM 700 microscope that was purchased 7 years. This microscope has been a workhorse that has provided JJPVAMC researches with high-resolution laser scanning confocal imaging for many years. However, with advances in imaging technology, this microscope is now lacks the sensitivity and important functionalities that are essential for high performance confocal/multiphoton imaging and in vivo imaging applications. The goal of this application is to replace an outdated Zeiss LSM700 microscope with an optimally configured and fully functional confocal/multiphoton microscope system that will be be made available to JJPVAMC investigators. We propose to replace the LSM 700 system with a Zeiss LSM 980 confocal/multiphoton inverted laser-scanning microscope with Airyscan detection for 3D super-resolution imaging. The LSM 980 confocal/multiphoton system will be placed in a multiuser environment. Technical support as well user training will be provided to support all VA research projects that might benefit from high-end imaging. Acquisition of an LSM 980 confocal/multiphoton system will provide a cutting-edge system for high resolution laser scanning confocal/multiphoton microscopy and related high-end optical imaging techniques.

Public health relevance
The Research & Development Program at the James J. Peters VA Medical Center (JJPVAMC) supports a variety of core equipment. Among the most utilized core equipment items is a Zeiss LSM 700 microscope that was purchased 7 years. This microscope has has provided JJPVAMC researches with high-resolution laser scanning confocal imaging for many years. However, with advances in imaging technology, it is now lacks the sensitivity and important functionalities that are available in current microscopes. This application proposes to replace the LSM 700 system with a Zeiss LSM 980 confocal/multiphoton inverted laser-scanning microscope with Airyscan detection for 3D super-resolution imaging. Acquisition of an LSM 980 confocal/multiphoton system will provide a cutting-edge system for high resolution laser scanning confocal/multiphoton microscopy and related high-end optical imaging techniques that will be made available to all VA research projects that would benefit from high-end imaging.